Bacteriophage diversity, dynamics, function, and exploitation

Bacteriophages are the most numerous biological entities in the biosphere. The phage population is also
dynamic, old, and not surprisingly, enormously diverse genetically. Bacteriophage genomes are replete with
genes of unknown function and because of their overall diversity, phage genomes represent the largest
reservoir of novel genes of unknown function. Although a small number of phages have been studied in
enormous detail, our lack of a deeper understanding of the broader diversity of phages represents a
substantial limitation. In particular, as the threat of antimicrobial antibiotic resistance continues to swell, the
therapeutic use of phages to control bacterial infections has garnered substantial attention, but a greater
understanding of phage biology and the determinants of phage-bacterium interactions is now imperative.
The dynamic interaction between bacteria and their viruses has markedly shaped the genomic profiles of both
bacteria and bacteriophages. Lytic infection of bacteria by their phages typically results in cell death, imposing
a strong selection for survival mechanisms. The discovery of restriction-modification (R-M) system marked the
beginning of the elucidation of bacterial defense systems, but other systems quickly followed, and CRISPR-
Cas phage defense has become widely recognized. It is notable that although these genetic systems were
discovered by exploring the basis of host preferences of the phages, R-M and CRISPR-Cas have fueled major
revolutions in biotechnology, harnessing the great enzymatic efficiency and specificity, finely tuned by billions
of years of evolution. The discovery of new phage defense systems has been an especially active area of
discovery, with dozens reported in the past few years, and seemingly many more awaiting recognition.
A collection of over 22,000 individual phages isolated on bacteria within the phylum Actinobacteria – 4,400 of
which are completely sequenced and annotated – provide a powerful resource for investigating bacteriophage
diversity, evolution, origins, and dynamics. A second and newer major resource is a collection of over 500
individual clinical isolates of nontuberculous mycobacteria (NTM), including the opportunistic pathogen
Mycobacterium abscessus. M. abscessus infections are prevalent among people with cystic fibrosis and some
other immune disorders and are intrinsically resistant to most antibiotics and clinically very difficult to treat. The
therapeutic use of phages for treating these infections shows some promise, but broader implementation is
restricted because of the extreme and unpredictable variations in the phage infection profiles of M. abscessus
isolates. These dual resources thus provide a powerful system for exploring the determinants of phage host
range at a strain-specific level, in which bacterial defense systems, prophage-encoded defense systems, and
plasmids all play critical roles. Exploring these dynamics will provide key insights into the drivers of microbial
diversity and evolution and advance the prospects of bacteriophages to become key elements in the treatment
of diseases caused by Mycobacterium pathogens.

Public health relevance
Project Narrative Bacteriophages are the most numerous organisms in the biosphere and profoundly influence microbial diversity, bacterial pathogenesis, and biotechnological advances. Dynamic bacteriophage-bacterium interactions contribute to narrow patterns of host specificity by phages, driven by bacterially encoded defense systems, prophage-mediated defense systems, and plasmids. Elucidating these systems and their roles in phage host range will advance our understanding of microbial dynamics and fuel the development of phage-based therapeutics.